Admin Core - Britton

Project Summary.
The BCM-CARBIRU Administrative Core is structured to provide a framework for the integration of
the three research projects and the two scientific cores, a plan for scientific and fiscal management,
and a steering committee to facilitate decision making on key topics by the project leaders. This
project will be directed by Dr. Britton and he will serve as the administrative liaison with the NIH. Dr.
Maresso and Dr. Lemon will serve as co-directors as this is a multi-PI proposal between the three
investigators. A detailed plan for the interaction of the BCM-CARBIRU team is provided, as well as a
plan to engage the broader Baylor College of Medicine and Texas Medical Center community in
combating antimicrobial resistance. To stimulate this interaction, we propose a pilot project program
with matching funds from Baylor College of Medicine to augment the research proposed in the BCM-
CARBIRU.